Emory National Primate Research Center: Building Automation System Upgrade

SUMMARY/ABSTRACT
This application seeks five years of continued support for the P51 Base Grant (OD 011132) for the operation of
the Emory National Primate Research Center (ENPRC) of Emory University. The overarching goals of the
ENPRC are to conduct research programs focused on scientific problems relevant to human health and the
NIH mission by providing resource infrastructure and expertise in appropriate scientific and veterinary
specialties and to ensure the Center’s ability to serve as a resource to Core and Affiliated Scientists, as well as
to other scientists regionally, nationally and internationally. During the 2016 - 2021 reporting period, the
ENPRC has recorded remarkable progress, as evidenced by numerous (>550) publications, construction of
new animal facilities, and continued robust research funding. In addition, the ENPRC has maintained
outstanding core research programs and provided resources and services to a broad multidisciplinary network
of affiliate and collaborative investigators throughout the region and nation. We utilize a building automation
system to monitor and control various electric, electronic, and mechanical systems for efficient and reliable
operation of the building support infrastructure. This supplement proposal seeks support to upgrade our
current Siemens Building Automation System (BAS), which is no longer supported by Siemens and presents
vulnerability to potential cyberattacks. The upgraded system will enable more reliable and secure building
control as well as optimization of energy consumption in the three main research buildings at the ENPRC Main
Station. This upgrade is essential not only for efficient and reliable building operations but also for the secure
network infrastructure that supports over $140 million in NIH-funded research at the ENPRC. This proposed
project is within the scope of the parent award; however, there is no overlap with work already funded in the
parent award.

Public health relevance
NARRATIVE This administrative supplement application seeks support to upgrade our current Building Automation System to enable more reliable, efficient building operations as well as better protect the Center from potential cyberattacks. The Emory National Primate Research Center’s mission is to conduct and support innovative biomedical and behavioral research by Core and Affiliated Scientists in order to improve the health and well- being of human and nonhuman primates.